Control Mechanisms of Human Voltage Gated Proton Channels, hHv1

Project Summary/Abstract
The voltage gated proton channel (HV1) exists in many human tissues and plays numerous roles vital
to human health. For example, it contributes to bacterial killing by white blood cells, sperm
maturation and mobility, histamine release by basophils, B lymphocyte signaling, and airway fluid
regulation. Abnormal HV1 function has been implicated in breast cancer metastasis, brain damage in
ischemic stroke, and exacerbation of chronic lymphocytic leukemia. As its gene was not reported
until 2006, HV1 is a newcomer to the voltage gated ion channel family. Its structure is unique in
resembling a crucial component of all voltage-gated ion channels, namely the voltage-sensing
domain that detects membrane potential and transduces this into channel opening or closing. Its
newcomer status, unique structure, and essential roles in human health and disease make
understanding HV1 function and dysfunction highly significant.
The DeCoursey lab has been deeply involved in the study of HV1, from discovering its existence in
mammalian and human cells, to identifying its role in a number of human cells and tissues, to finally
dissecting the molecule itself to identify which parts perform the major functions. Over the next five
years we intend to expand our knowledge of this important molecule at multiple levels, building on our
recent progress. Structure-function knowledge is crucial both for understanding mechanisms and for
drug design. Much has been learned about structure-function relationships from mutations to the
human channel. We believe that it will be more productive in the future to explore structure-function
relationships in the highly variable naturally-occurring HV1 in diverse species. An exciting new
direction will be studying the involvement of cholesterol and membrane lipid “rafts” in the
physiological regulation of hHV1 function. Another focus will be to determine the relationship between
hHV1 mutations in B lymphocyte malignancies.

Public health relevance
Project Narrative Voltage-gated proton channel are proteins that help white blood cells kill bacteria, sperm fertilize eggs, and heart muscle remain healthy. But their abnormal function can promote leukemia, breast cancer metastasis, autoimmune diseases, and brain damage in stroke. By discovering how proton channels work, and which of their parts are important, this project will enable designing drugs to control their activity.